Psychobiological Mechanisms Underlying the Association Between Early Life Stress and Depression Across Adolescence

ABSTRACT
The transition through adolescence is characterized by a striking increase in symptoms and rates of
depression. In fact, the majority of first episodes of MDD occur during adolescence. One-quarter of
adolescents experience an episode of Major Depressive Disorder (MDD) by the end of their teenage years,
and almost half of adolescents with a depressive episode experience a recurrence within three years. In
attempting to identify factors that contribute to this high prevalence of depression in adolescence, investigators
have focused on the adverse effects of exposure to stress occurring during childhood, or early life stress
(ELS). ELS, including abuse, neglect, parental loss, and interpersonal stress, is associated with a marked
increase in risk for subsequent depression. We do not yet understand, however, the mechanisms by which
ELS contributes to this risk, thus hampering effective prevention and intervention efforts with adolescents. The
proposed project is designed to examine trajectories of two psychobiological mechanisms that may explain
how ELS increases risk for depression during adolescence: increased stress reactivity and blunted reward
sensitivity. This focus on the trajectories of stress and reward systems is particularly salient in adolescence
given that both of these systems undergo significant change and reorganization during this sensitive period of
development. We propose to follow longitudinally 220 boys and girls who have already completed two
comprehensive assessments (beginning at 9 to 12 years of age), two years apart, of their exposure to ELS,
psychobiological functioning (including behavioral, cognitive, endocrine, and neural assessments of stress
reactivity and reward sensitivity), and MDD symptoms and diagnosis. We will leverage data obtained from this
large and richly-characterized sample of children to examine prospectively the developmental mechanisms by
which ELS affects the onset and course of depression during adolescence. Specifically, we will integrate data
from the participants’ first two assessments completed in late childhood and early adolescence with new data
that we propose to obtain at two additional assessments conducted in mid and late adolescence, a
developmental period during which the incidence of MDD peaks. Specifically, we will continue to assess
clinical characteristics, information-processing biases, endocrine functioning, and brain function, structure, and
connectivity. Collectively, this approach will allow us to analyze the effects of ELS on trajectories of
psychobiological and clinical functioning from childhood through late adolescence, and on deviations from
normative trajectories of these constructs. Findings from this project will inform efforts to generate personalized
targets in order to tailor prevention and treatment programs to adolescents who have been exposed to ELS
and who, consequently, are at high risk for developing MDD.

Public health relevance
Project Narrative/Public Health Relevance: Although early life stress (ELS) is a significant risk factor for the development of depression during adolescence, the psychobiological mechanisms through which ELS confers this heightened vulnerability are poorly understood. In this project we will test our formulation that exposure to ELS leads to depression during adolescence by altering adolescent-typical trajectories of stress reactivity and reward sensitivity. Findings from this project will inform efforts to generate personalized targets in order to tailor prevention and treatment programs for adolescents who have been exposed to ELS and, consequently, are at high risk for developing depression.